sEcad as a novel target and therapy for IGF-1R expressing tumors

ABSTRACT
Breast cancer and Alzheimer's disease (AD) are common diseases of aging, and independently are
responsible for significant morbidity and mortality in the United States. Recent clinical studies and large
prospective population-based analyses have surprisingly suggested the presence of an inverse association
between cancer and Alzheimer Disease (AD), one where cancer decreases the risk of development of
dementia, and even AD. Other studies, however, have reported that breast cancer survivors demonstrate a
significantly higher probability for AD, and implicated the ApoE e4 allele specifically in this interconnection.
Therefore, the role of cancer in AD development remains highly controversial. Moreover, the mechanisms
responsible for this interconnection remain largely unknown. It is the goal of this administrative supplement to
R01CA194409, entitled “sEcad as a novel target and therapy for IGF-1R expressing tumors”, to investigate
whether the development of breast cancer, with and without the benefit of our tumor-targeting anti-sEcad
antibodies, have an impact on Alzheimer's disease in the novel APP/PS1;Neu compound transgenic mouse
which develops both AD (APP/PS1 allele) and breast cancer (MMTV-Neu). To this end, we will temporally
evaluate alterations in Aβ pathology, neuroinflammation and cognitive function in the APP/PS1;Neu double
transgenic mouse model, which temporally compounds breast cancer and AD pathology.
Heath Impact: The proposed administrative supplement will begin to address the very significant question of
whether breast cancer has an impact on AD development, and enable the elucidation of mechanisms
underlying such a putative interconnection. Completion of the proposed studies will provide the preliminary
data necessary for future R01 grant applications.
.

Public health relevance
NARRATIVE Breast cancer and Alzheimer's disease (AD) are common diseases of aging, and independently are responsible for significant morbidity and mortality in the U.S. Recent clinical studies and large population- based analyses have surprisingly suggested an inverse association between cancer and Alzheimer's Disease (AD), although the mechanisms underlying this interconnection are currently unknown. The goal of this administrative supplement is ascertain whether we can replicate this inverse association between breast cancer and AD using a novel APP/PS1;Neu compound transgenic mouse model, and by interrogating Aβ pathology, neuroinflammation and cognitive function.